Investigating the origin and role of the IgA+ B cell response to intracerebral hemorrhage

PROJECT SUMMARY
Stroke is the second highest cause of death and the leading cause of disability globally. Intracerebral
hemorrhage (ICH) is the second most prevalent form of stroke with a high mortality of ~40% and high rates of
long-term cognitive decline in surviors.1-4 The B cell response to stroke is well established, and in ischemic
stroke models in mice B cells have been linked to slow cognitive decline.5 However, the B cell response to ICH
is currently unknown and represents a major gap in knowledge. Our preliminary work has demonstrated an
influx of IgA+ B cells into the brain starting 8 weeks post-ICH, similar to the IgA+ B cell aggregates in the brain
and spinal cord in multiple sclerosis patients and experimental autoimmune encephalitis (EAE) mouse
models.8 While IgA+ B cells are traditionally associated with mucosal tissues like the small intestine, their
presence in the CNS is spurring new inquiry into the function of these cells in the context of neuroinflammation.
I hypothesize that there is a late influx of IgA+ B cells from the meninges into the brain post-ICH that
serves a neuroprotective role in post-stroke recovery. The goal of this project is to utilize a murine
collagenase injection model of ICH to elucidate the origin and function of brain-infiltrating IgA+ B cells in post-
ICH inflammation and recovery in the following aims. Aim 1. To determine the timing of the IgA+ B cell influx
into the post-ICH brain over 16 weeks, investigate whether these cells are locally proliferating or constantly
recruited, determine whether tertiary lymphoid structures (TLSs) exist in the post-ICH brain, and identify the
brain regions IgA+ B cells localize to. Aim 2. To elucidate the origin of brain-infiltrating IgA+ B cells post-ICH
using both meningeal plasma cell depletion and clonal analysis of B cells from blood, gut, meninges, and brain
B cells using B cell receptor sequences generated by single-cell RNA-sequencing. Aim 3. To determine the
effector functions of brain-infiltrating IgA+ B cells on post-ICH recovery. These experiments will provide much
needed insight on the role of B cells in the brain in the weeks and months after ICH, and specifically on IgA in
the context of stroke and neuroinflammation more broadly. My results therefore have the potential to shape our
understanding of the adaptive immune response to ICH and inform therapeutic approaches to mitigate the
long-term effects of this disease on patients and families.

Public health relevance
PROJECT NARRATIVE A robust immune response to intracerebral hemorrhage (ICH) is well documented but the B cell response in the post-ICH brain remains poorly understood. This grant proposes a thorough characterization of the B cell response to ICH over time, with particular emphasis on understanding the phenotype and function of brain- infiltrating IgA+ B cells. This work will therefore have important implications for our understanding of the adaptive immune response to brain injury and may guide therapeutics targeting post-ICH inflammation-induced damage.